Investigating the Effect of Caspases and Anti-Viral Responses on KSHV Tumorigeniesis

PROJECT SUMMARY
Kaposi's sarcoma, caused by Kaposi's sarcoma-associated herpesvirus (KSHV), remains a major health
challenge for people living with HIV and other immunocompromised patients. While research has historically
focused on the latent cycle of KSHV infection, recent evidence demonstrates that viral reactivation to the lytic
cycle is crucial for tumor development through growth factor secretion and maintenance of latently infected
cells. This central role of the lytic cycle offers a new therapeutic opportunity. Therefore, there is a need to
discover strategies to block KSHV reactivation and its associated pro-tumor activities, as a starting point to
develop new targeted therapies. Type I interferons (IFNs) potently block KSHV replication at early stages of
the lytic cycle. However, direct IFN administration causes severe systemic side effects in patients, limiting its
use. We recently discovered that KSHV hijacks cellular caspase enzymes to suppress IFN responses. This
finding suggests that caspase inhibition could restore antiviral IFN responses in infected cells and serve as an
alternative approach to leveraging IFN response for therapy. However, we do not yet know whether
manipulating caspase activity and type I IFNs can block the pro-tumor activities of lytic replication. This is
because IFN responses have been studied in conventional 2D cell culture infection models that poorly mimic
KSHV infection in tumors. To address this gap, we will use a recently developed 3D primary human endothelial
cell organoid model. These organoids better recapitulate characteristics of Kaposi’s sarcoma tumors, including
stable maintenance of the latently infected cell mass through spontaneous viral reactivation and changes in
cell morphology and differentiation. We will use this new model to test the hypothesis that activation of the IFN
pathway, either through direct IFN administration or caspase inhibition, disrupts two key tumorigenic processes
due to lytic reactivation: growth factor secretion and maintenance of the latently infected cell population. We
will first dissect type I IFN and caspase signaling during KSHV infection in organoids and compare it to IFN and
caspase activation in Kaposi’s sarcoma tumor tissue (Aim 1). We will then test how inducing IFN responses
through direct IFN administration or caspase inhibition affects growth factor secretion and maintenance of the
latently infected cell population (Aim 2). This study will thus evaluate the potential for modulation of caspases
and IFN responses in blocking KSHV tumorigenic activities and as therapeutic strategy against Kaposi’s
sarcoma. Success could lead to new targeted treatments for Kaposi’s sarcoma while providing a foundation for
future mechanistic studies of KSHV pathogenesis.

Public health relevance
NARRATIVE Kaposi’s sarcoma is a tumor caused by Kaposi’s sarcoma-associated herpesvirus (KSHV) in AIDS and transplant patients, and it is currently poorly treatable. Manipulating the cellular antiviral response reduces viral replication, which is necessary for tumor formation, pointing to a potential strategy for targeted therapy. Using a new disease-relevant model of infection, we will investigate how these antiviral responses impact tumor-related processes during KSHV infection and to what extent they can be leveraged as new Kaposi’s sarcoma treatments.